Ultra-High-Throughput Plate Reader for Drug Discovery Using All-Optical Electrophysiology

Ultra-high-throughput plate reader for drug discovery using all-optical electrophysiology
Neurological disorders remain a major unmet medical need in the United States and worldwide, accounting for
more than 10% of the total years of healthy life lost in developed countries. Drug discovery for diseases of the
nervous system has been challenging in comparison with other disease areas. A major barrier to progress in
neuroscience drug discovery is the lack of translatable assays, models, and technologies that can be used to
predict human efficacy with both the information content and throughput needed for rapid identification and
optimization of therapeutic candidates. As such, there is a strong commercial need for scalable assay and
instrument platforms that can be leveraged throughout the CNS-based drug screening and discovery pipeline.
The Swarm microscope, developed through Phase I and Phase II efforts, leverages QuellTX’s proprietary
Optopatch technology, enabling the recording of both voltage and calcium activity under optical stimulation from
24-objectives simultaneously. Our instrument has the potential to transform high-throughput screening (HTS) by
leveraging our advanced optogenetics tools in 96-, 384-, and 1536-well plate formats. The instrument was
successfully used to screen our 200,000 internal compound library against Nav1.7, a genetically validated target
for pain, on our Spiking HEK cell assay demonstrating the utility of the Swarm for CNS-based therapeutic
discovery.
In this Phase IIB application, we will leverage these technologies and expertise towards full commercialization
by building the next generation Swarm 2.0 platform with significantly improved functionality, throughput, and
stability. First, we will develop a camera-based Swarm 2.0 instrument with upgraded illumination, stimulation,
and detection subassemblies and pair these capabilities with new analysis tools. Next, we will develop two
differentiating Swarm 2.0 compatible optogenetic classes of assays: 1) target-based HEK cell assays for voltage-
gated Na channels, representing a major class of drug targets for CNS disorders, and 2) intact, native cell assays
in neurons, enabling critical bridging secondary assays for therapeutic discovery. After the instrument is
constructed and validated, we will optimize Nav1.8, a drug target for pain indications currently pursued by the
pharmaceutical industry, and secondary multiplexed spiking HEK assays for HTS compatibility on the platform.
Finally, we will perform a screening campaign using an in-house 14,000-compound diversity focused small
molecule library and incorporate AI-assisted structure-guided drug discovery to improve screening efficiency and
effectiveness. This screen will be followed by hit confirmation and selectivity counter-screens. At the conclusion
of this Phase IIB work, the Swarm 2.0 platform will be fully validated for commercialization, generating chemical
hits that can be optimized for pain therapeutics and more broadly by enabling execution of HTS compound
screens with the potential for expansion into new assay types. Success in Phase IIB has the potential for
significant impact both in neuroscience research and in enabling our novel, proprietary platform for drug
discovery for CNS-based disorders such as severe epilepsy and pain, areas of significant unmet medical need.

Public health relevance
Project Narrative There is a vital unmet medical need for new and effective therapeutics for neurological disorders, yet the drug development process remains a challenge due in large in part to a lack of translatable assays, models, and technologies to identify novel drug candidates. QuellTX has built an industry leading platform that combines cell-based disease models, engineered proteins, custom automated microscopes, and advanced analytics to allow visualization and characterization of electrical signaling in excitable, disease-relevant cell types such as neurons. Here, we propose to build an ultra-high throughput screening instrument that leverages our proprietary optogenetic tools for light-based stimulation and recording of electrophysiology and sensitive camera-based detection for robust measurements of cellular activity whereby successful execution of the proposal will enable a broad suite of novel assays on a wide range of excitable cell types for drug discovery in disorders of the nervous system, including areas of significant need such as chronic pain and severe epilepsy.